Viral and Host Determinants of Endosomal Trafficking during HBV Infection

PROJECT SUMMARY
Hepatitis B virus (HBV) is a DNA virus belonging to the hepadnavirus family and is responsible for chronically
infecting over 250 million individuals worldwide, resulting in nearly a million annual deaths due to severe liver
diseases such as cirrhosis and hepatocellular carcinoma. Unfortunately, anti-viral treatments fail to cure HBV
infection due to the tenacity of covalently closed circular DNA (cccDNA), which is the template for viral
transcription and subsequent translation of all viral products necessary to establish and sustain HBV replication.
Much is learnt about HBV replication events post cccDNA production, however little is known about the
intracellular trafficking steps that are required for the initial cccDNA production to establish productive infection.
My PhD dissertation research aims to define the role of the viral capsid in endocytic trafficking during HBV
infection (Aim 1). We have identified a series of HBV capsid mutants which have a unique phenotype in that
during infection, they do not lead to productive infection (i.e., no cccDNA formation), however cccDNA can form
during transfection via intracellular amplification, which bypasses the viral entry steps during infection, indicating
that there is a block in the viral entry steps during infection with the mutant viruses that are not required during
transfection. We plan to monitor post-entry trafficking events of WT and mutant HBV (Aim 1.1) and will further
define the role of the viral capsid in directing endosomal trafficking through use of capsid inhibitors that induce a
similar effect to our capsid mutants (Aim 1.2). These capsid inhibitors are in active clinical development;
therefore, it is crucial that we understand what entry steps are modulated by them. Addressing questions related
to HBV entry has been made possible by the identification of the viral entry receptor, hNTCP, however its
expression cannot confer susceptibility to HBV infection in HEK293 cells, which can support cccDNA formation
during transfection but cannot support cccDNA formation during infection, phenocopying the effects of the HBV
capsid mutations and inhibitors. The second portion of this project will focus on defining the role of host cells in
HBV trafficking during infection (Aim 2). We will address the endocytic trafficking of HBV in HEK293-hNTCP cells
to identify where the block(s) in infection occurs, rendering these cells non-susceptible (Aim 2.1). To help identify
the host determinants, beyond the entry receptor hNTCP, that may play a role in HBV entry, we have designed
a split GFP-based HBV reporter system that will be used to isolate a subpopulation of HepG2-hNTCP cells that
are highly susceptible to HBV infection (Aim 2.2) and perform RNA sequencing analysis to identify differentially
expressed genes between susceptible vs. non-susceptible cells. These proposed studies will increase our
understanding of HBV entry and identify the essential endocytic trafficking steps that lead to productive infection.
Altogether, the successful accomplishment of my dissertation will have profound impacts on (1) understanding
the essential events of HBV endosomal trafficking and entry and (2) identifying the HBV capsid and novel host
determinants that are critical for HBV entry and productive infection.

Public health relevance
PROJECT NARRATIVE Hepatitis B virus (HBV) is a small enveloped DNA virus responsible for chronically infecting over 250 million individuals worldwide. Our proposal aims to elucidate the entry steps for HBV in susceptible cells and how these steps are blocked in non-susceptible cells. Our project will provide the basis for identifying how the viral capsid can direct endosomal trafficking post internalization, a novel proposal in the field of HBV and we will further develop an efficient in vitro infection model and identify novel host determinants that play a role in HBV entry.